JCOIN phase II innovation hub

PROJECT SUMMARY/ABSTRACT
Access to substance use disorder (SUD) treatment remains inadequate for many groups, particularly those in
Southern jails. Black individuals and people experiencing homelessness are disproportionately represented in
carceral populations, yet they lack equitable access to medications for opioid use disorder (MOUD), including
methadone and buprenorphine (3-8). Further, these populations are rarely prescribed MOUD upon release
from incarceration, when the risk for death from overdose is highest.(8) MOUD can be lifesaving, yet
represents one part of the recovery ecosystem; medications with a similar effect size are not yet available for
individuals with a non-opioid SUD including stimulants.(9-11) An individualized yet scalable approach matched
to individual needs and substance use, is required.(12-14) Peer recovery coach (PRC) models which engage
individuals with lived experience to conduct motivational interviewing and a warm handoff to medical,
behavioral, and community-based services, are associated with improved SUD-related outcomes and can be
delivered via telehealth.(15-19) Nonetheless, there is less research assessing the implementation and
effectiveness of PRCs in jails, except for linking persons with HIV to community care upon release, despite the
heightened vulnerabilities individuals with SUD face as they transition from carceral settings.(20-22) The
proposed JCOIN II Innovation Hub will implement and rigorously evaluate a PRC program at three high-
throughput jails in the Atlanta, Georgia area. The Innovation Hub will adapt and evaluate an established SUD
virtual peer recovery (telehealth) model (LINCS UP) to the jail setting. Project implementation will be guided by
the EPIS framework and developed in collaboration with an established community advisory board including
individuals with a history of SUD and justice involvement. Outcomes will be measured across the RE-AIM
framework.(23) PRC effectiveness will be evaluated through a stepped wedge cluster randomized clinical trial.
Primary outcomes will include engagement in addiction care while in jail and successful linkage to community-
based care upon release. Secondary outcomes will include, but are not limited to ongoing substance use,
recovery capital, overdose events, mortality, and recidivism. Finally, the Innovation Hub will conduct a cost
effectiveness analysis of the jail PRC program. Following consensus recommendations, this analysis will
include cost considerations from both healthcare and societal perspectives.

Public health relevance
PROJECT NARRATIVE Access to substance use disorder (SUD) treatment remains inadequate for many groups, particularly Black individuals and people experiencing homelessness, who are disproportionately represented in carceral populations. This Hybrid Type 2 effectiveness-implementation trial will implement and evaluate the effectiveness, including cost effectiveness, of peer recovery coaches using a virtual model at three jails in the Atlanta, Georgia area. Results will inform other law enforcement and public health organizations considering their own peer recovery coach program, including rapidly scalable virtual-based programs.